TRIMETREXATE VS TRIMETHOPRIM/SULFAMETHOXAZOLE FOR PNEUMOCYTIS PNEUMONIA

A multicenter controlled trial of trimethoprim-sulfamethoxazole versus for prophylaxis of pneumocystis carcinii pneumonia in AIDS patients receiving azidothymidine.